Cardiac Magnetic Resonance Imaging Guided Risk Stratification in Cardiac Sarcoidosis

PROJECT SUMMARY/ABSTRACT
An estimated 200,000 Americans live with sarcoidosis. Sarcoidosis is a multisystem granulomatous disease of
unknown etiology. Up to a quarter of patients with sarcoidosis may have cardiac involvement. Cardiac
sarcoidosis is the second leading cause of sarcoidosis-related mortality, accounting for up to a quarter of
deaths from sarcoidosis. Most deaths from cardiac sarcoidosis are due to ventricular arrhythmias.
Cardiovascular magnetic resonance imaging is frequently used in the evaluation of patients with suspected or
known cardiac sarcoidosis. In this proposal, we aim to investigate cardiovascular magnetic resonance imaging
biomarkers that may be associated with adverse outcomes in patients with suspected or known cardiac
sarcoidosis. Using this information, we will identify integrative phenotypes – composed of biomarkers from
cardiovascular magnetic resonance imaging, demographics, and clinical characteristics – associated with
adverse cardiac outcomes. The proposed work will establish high- and low-risk phenotypes of cardiac
sarcoidosis patients that predict benefit from immunosuppression and/or implantable cardioverter-defibrillators
to prevent sudden arrhythmic cardiac death and other cardiac sarcoidosis-related adverse outcomes. These
data will lay the groundwork for prospective studies testing the strategy of using the integrative phenotypes to
select cardiac sarcoidosis patients for treatments. Selective and appropriate use of these treatments could
improve long-term clinical outcomes in patients with cardiac sarcoidosis, in particular by preventing ventricular
arrhythmia-related sudden cardiac death.

Public health relevance
PROJECT NARRATIVE An estimated 200,000 Americans live with sarcoidosis. Cardiac sarcoidosis is the second leading cause of sarcoidosis-related mortality, accounting for up to 25% of deaths from sarcoidosis. Most deaths from cardiac sarcoidosis are due to ventricular arrhythmias. The proposed work, if successful, would identify a method to accurately distinguish patients who would versus would not benefit from treatment to prevent sudden arrhythmic death from cardiac sarcoidosis.